Novel Approaches to Assess Metabolic Dysregulation in Pulmonary Hypertension

Pulmonary hypertension (PH), an increasingly common condition characterized by progressive remodeling of
the pulmonary vasculature, is an incurable disorder associated with significant morbidity and mortality. In a
large retrospective cohort of >100,000 veterans diagnosed with PH, we recently reported that PH related to
underlying heart (Group 2), or lung (Group 3) disease was most common and associated with the worst
prognosis. Strikingly, existing therapies for PH are neither effective nor indicated in these common PH
subgroups. Our preliminary studies highlight broad metabolic dysregulation in mice, rats, and subjects with
Group 3 PH. Because existing therapies fail to reverse underlying metabolic derangements that cause
pulmonary vascular cell proliferation and remodeling, this proposal seeks to better defining underlying
mechanisms of metabolic dysregulation in PH. Circulating platelets will be used as a unique biosensor to
study mitochondrial and metabolic dysfunction in PH. The PI will use bioinformatics to integrate the
experimental results with PH clinical features. We hypothesize that analysis of platelet bioenergetics and
metabolic function will reflect similar alterations in pulmonary vascular cells and serve as a metabolic
biosensor for evaluation of PH pathogenesis, progression, and treatment. This hypothesis will be examined in
two specific aims using sera, platelets, and pulmonary artery smooth muscle cells (PASMC) from
experimental and clinical samples. Aim 1 will explore critical hubs of metabolic dysregulation in
PASMCs and platelets isolated from PH rats. The Sugen 5416-hypoxia rat model will be employed to
isolate PASMCs and platelets from control and PH animals. The PI will be trained to characterize PH in this
model measuring hemodynamics, vascular remodeling, and right ventricular hypertrophy. Mitochondrial
function will be defined in PASMCs and platelets using an array of assays established in the mentor's lab.
Advanced metabolomics and isotope tracing for targeted metabolite analysis will be conducted under the
training of the Co-Mentor. Temporal changes in these parameters over time will be integrated with
hemodynamics and vascular remodeling. Aim 2 will examine mitochondrial and metabolic dysregulation
in de-identified platelets and plasma from clinically phenotype Group 3 PH patients. Platelets and
plasma from Group 3 PH, and age-matched controls will be subjected to mitochondrial and metabolomic
studies described in Aim 1. Bioinformatics approaches will elucidate if co-morbidities correlate with alterations
in metabolic hubs using multi-scale associations between participant characteristics, bioenergetic, and
metabolomic data. These findings will inform critical pathways of metabolic dysregulation that may be
therapeutically targeted to improve outcomes in PH. These studies and career development activities will
provide an exceptional foundation for the PI to become a successful, independently funded VA scientist to
improve the care and outcomes of veterans diagnosed with PH.

Public health relevance
This project is to identify targets of metabolic dysregulation which promote pathogenesis in pulmonary hypertension (PH). PH has been reported to affect nearly 1 in 30 US veterans, and is currently an incurable disorder with significant decreases in quality of life and eventually leads to death. Dr. Smith's previous research involved identifying mechanisms of metabolic dysregulation by exposures to military personnel deployed in high-risk areas, and he seeks to apply his expertise of metabolism to PH. This project will identify critical targets associated with poorer prognosis by using platelets from individuals with PH as a biosensor. These results will be validated in a preclinical rat model of PH. Therefore, the proposed research will use advanced analytical and systems-biology related techniques to improve our understanding of the underlying mechanism of PH pathogenesis and to ultimately improve the care of veterans with the disease.